Formation and function of lamellipodial morphology in 3D microenvironments

Project Summary
Dendritic cells are the sentinels of the immune system. They patrol the body looking for antigens and then migrate
to a lymph node to communicate what they found to T cells and other cells of the adaptive immune system.
These professional migrators and searchers are a critical component of human immunity, and their migration is
targeted or hijacked by multiple pathogens including some pox and herpes viruses, tuberculosis, and anthrax.
Since dendritic cells can activate cytotoxic T cells to attack cancer cells, their migration also plays a role in cancer
immunotherapy strategies. Many cells, including dendritic cells, migrate by extending lamellipodia. Lamellipodia
are thin, planar protrusions that have been extensively studied for cells migrating on 2D surfaces, such as glass
coverslips. Dendritic cells use lamellipodia to find a path through crowded 3D environments and to enter lym-
phatic vessels. Lamellipodia and the actin network that composes them have been studied for decades. How-
ever, most molecularly detailed models of lamellipodia regulation and function were derived from studying cells
on 2D surfaces, so we still do not know how cells initiate and extend lamellipodia in 3D environments. In this
project, we will investigate how actin nucleators organize to generate sheet-like lamellipodial morphologies in
the absence of a surface to guide their generation, as well as how actin nucleators organize to direct the exten-
sion of lamellipodia within crowded 3D environments. As a model of dendritic cell migration through peripheral
tissues, we will study migration though 3D fibrous collagen matrices. Widely available microscopic techniques,
such as confocal microscopy, cannot image cells in 3D collagen with the spatial and temporal resolution required
to measure the organization of actin nucleators in lamellipodia. However, recently developed techniques, such
as light-sheet microscopy, are just beginning to be able to do so. Since light-sheet microscopes can produce
massive datasets, interpreting and even simply visualizing such large amounts of data requires sophisticated
computing workflows. We will develop the needed computational workflows as we investigate lamellipodia form
and function in 3D environments.

Public health relevance
Project Narrative Cell migration is critical to many physiological and pathological processes, including embryogenesis, wound healing, immune function, and cancer metastasis. Lamellipodia are thin, sheet-like protrusions that facilitate cell migration in diverse environments. This project combines high-resolution light-sheet microscopy, computer vi- sion, and molecular biology techniques to study the formation and function of lamellipodia in 3D fibrous matrices that mimic in vivo microenvironments.